Core 2: Methodology

PROJECT SUMMARY: Methodology Core
This Core focuses on economic evaluation approaches, tools, and measures to support new and existing
interdisciplinary research collaborations. Despite decades of research supporting a chronic disease approach
to substance use disorder treatment and recovery, uptake and sustainment remain low. Some of the most
important factors inhibiting adoption of evidence-based practices are concerns about the potential burden on
staff and other resources, as well as overall budget impact. Changing current practices requires not only
clinical evidence, but also consideration of additional costs and the reallocation of existing resources that will
result from the changes. Economic analysis can directly address these issues by providing a detailed
accounting of the costs to the provider of updating services, and more broadly inform “real-world” resource
allocation decisions by providing policymakers and payers with evidence on the net economic and health
impact of new approaches and their fiscal viability over time. This requires considering both costs and
consequences of a new intervention, often using a cost-effectiveness or cost-benefit analysis framework. The
overall aim of CHERISH (Center for Health Economics of Treatment Interventions for Substance Use Disorder,
HCV, and HIV) is to develop and disseminate economic evidence that informs substance use disorder policy
and HCV and HIV care of people who use substances. In this renewal period we will expand our focus to
outcome and implementation research that is conducted at the individual, system, and community levels with
the following specific aims: 1) to guide researchers in the design, implementation, and interpretation of
economic analyses of treatment for substance use disorder, and HCV and HIV among people who use
substances, and 2) to develop and apply methods that support economic evaluations for substance use
disorder, and HCV and HIV among people who use substances with a focus on intervention implementation
and adaptive interventions. Through the CHERISH Consultation Service and Research Affiliates Program, we
will contribute to the development of new grant proposals with explicit economic aims, and will continue to
connect with and advise qualifying researchers nationally to ensure that planned economic analyses are
methodologically sound and feasible. We will expand the CHERISH Research Affiliates program so it can
serve as a nationally-representative virtual community for researchers engaged in substance use disorder
treatment health economic research. Working with existing studies and integrating data from third-party
datasets and administrative records, we will develop analytic frameworks and tools for evaluating individual
and systems-level substance use disorder and related implementation interventions. We will also develop
economic evaluation methods for adaptive interventions. In collaboration with the Population Data & Modeling
Core, we will assist researchers in using external data to enhance interpretation of economic evaluation
results.